Evolution of bacterial communication systems

PROJECT SUMMARY/ ABSTRACT
Quorum sensing (QS) is an important form of bacterial communication used to coordinate gene expression and
group behaviors in a cell density-dependent manner. Many bacteria use a form of QS in which a signal synthase
produces a membrane-permeable small molecule to which a paired cytosolic receptor responds. Hundreds of
QS systems with diverse properties have been identified, many of which are important for the virulence of
pathogenic bacteria. How this diversity evolved is a question of fundamental importance to the field. In my early
postdoctoral work on the model QS system LasI-LasR from Pseudomonas aeruginosa, I observed that the
receptor, LasR, has not evolved to maximal signal sensitivity and that variants of both LasI and LasR tend to be
less selective than wildtype. Further, QS systems are often tightly regulated to ensure activity only occurs at a
specific cell density. Based on these observations, I hypothesize that QS systems evolve to balance signal
sensitivity, selectivity, and fitness. This proposal tests that hypothesis using the LasI-LasR model system. Aim 1
will investigate the costs and benefits of signal sensitivity using hyper- and hypo-sensitive LasR variants I
identified previously. I will measure the timing and level of QS activity in these mutants, the susceptibility of the
mutants to signal interference, and ultimately the fitness of the mutants in monoculture and in competition with
wildtype P. aeruginosa. Aim 2 will evaluate how P. aeruginosa responds to pressure on LasI-LasR signal
selectivity. I will use my recently identified non-selective LasI and LasR variants as a starting point for the in vitro
evolution of new signal selectivity. This aim will illuminate additional determinants of QS selectivity and will
generate tools for future research on the trajectory by which QS signal selectivity evolves. Together these aims
will deepen our understanding of the evolution of bacterial communication systems, are expected to facilitate
future research into the roles of these systems in polymicrobial communities, and will lead to new avenues for
understanding and treating infections. This research proposal will form the foundation of my applications for an
independent faculty position and the results I obtain are expected to help me successfully compete for future
funding. These experiments will be initiated during the K99 phase of the award and will include training in
bacterial co-culture, in vitro evolution, and biostatistical methods. Additionally, this proposal includes a career
development and training plan to complement my prior experience. I have assembled a multidisciplinary advisory
team to help me achieve my goals and my mentor, Dr. Greenberg, is a pioneer and expert in bacterial
communication with a long track record of successful mentorship. The training and support provided by this
award will enable me to achieve my long-term goal of establishing an independent research program focused
on bacterial signaling and physiology in complex environments.

Public health relevance
PROJECT NARRATIVE Whether in the environment or a human infection, bacteria live in communities where intercellular communication influences behaviors such as virulence. This proposal investigates the evolution of bacterial communication systems using quorum sensing in the pathogen Pseudomonas aeruginosa as a model. By uncovering selective pressures on these communication systems and the ways in which they diversify, the proposed experiments will lead to a better understanding of the function of bacterial signaling, to new insights into interactions in bacterial communities, and ultimately to new avenues for treating infections.